Multimeric prodrugs for pulmonary hypertension therapy

Abstract
Vascular injury with disruption of the endothelial barrier is an inevitable consequence of the
pathological processes contributing to the development of pulmonary hypertension (PH).
Despite earlier diagnosis and recent improvements in its clinical management, pediatric PH
remains ultimately fatal, with poor treatment outcomes and dismal prognosis. Centered on
developing an effective and safe therapy for PH in children, these studies will evaluate
cleavable multimeric prodrugs taking advantage of the increased vascular permeability
associated with this pathology to enhance uptake and provide a lasting therapeutic effect of
the drug cargo on the pulmonary vasculature, while minimizing off-target distribution and
systemic toxicity. This delivery strategy will be evaluated with non-prostanoid prostacyclin
mimetics exhibiting pleiotropic effects against PH. As small-molecule drugs, they have shown
promise in clinical trials, however their clinical utility is limited by rapid clearance and significant
systemic adverse effects. Guided by our prior work on the design of prodrugs for target-
specific delivery and the results of our proof-of-principle studies toward this project, we
hypothesize that multimeric prodrugs designed as reversibly assembled, covalent [polymer-
drug] complexes will achieve sustained presence of the prostacyclin analogs at therapeutically
adequate levels in the lung tissue, resulting in a strong and lasting suppression of the PH
development in a clinically relevant model recapitulating key features of the disease. This
hypothesis will be tested and the overall objective of this project will be attained by pursuing
the following specific aims: Aim 1 studies will focus on in vitro evaluation of the prodrugs by
comparatively determining their effects on cAMP accumulation, platelet activation, and growth
kinetics of proliferative smooth muscle cells; Aim 2 studies will comparatively examine
pulmonary uptake and biodistribution of a model macromolecular construct (Subaim 2a), and
evaluate therapeutic efficacy and toxicity of the multimeric prodrugs in a preclinical model of
PH (Subaim 2b). These studies are expected to have a lasting impact on the field by
demonstrating feasibility of using multimeric prodrugs with a cleavable chemical design to
improve safety and effectiveness of drug therapy while mitigating the risk for delayed adverse
effects due to accumulation of the carrier, and by implementing prodrug-based delivery to
enhance selectivity and extend the duration of the pharmacological activity of synthetic non-
prostanoid prostacyclin mimetics as an experimental new treatment for pediatric pulmonary
hypertension - a severe, ultimately fatal disease lacking curative treatment options.

Public health relevance
Project Narrative The present collaborative studies will evaluate and optimize a novel prodrug-based targeted delivery strategy for treating pediatric pulmonary hypertension, a severe disease with a poor prognosis, currently lacking curative treatment options. Prodrugs designed with the capacity to slowly disintegrate in the body will be used to improve target-specificity, while eliminating the concern for delayed adverse effects due to irreversible accumulation. The results of this project may facilitate the development, translation and clinical implementation of new prodrug-based delivery systems for more effective and safer therapy of pediatric pulmonary hypertension and other severe pulmonary vascular diseases.